Application of deep learning and novel survival models to predict MCI-to-AD dementia progression

Project summary/Abstract
Alzheimer's disease (AD) is a common and costly neurodegenerative disease that is characterized by a long
pre-clinical stage, including a prodromal stage of AD also referred to as mild cognitive impairment (MCI).
Many, but not all, MCI patients progress to AD dementia at varying rates. Among MCI patients, late stage
MCI patients progress to AD faster than early stage MCI patients: a faster annual cognitive decline with
loss of memory. As potential disease modifying drugs are tested for their ability to delay AD dementia, it
becomes critical to have tools that can better accurately predict MCI-to-AD dementia conversion. This would
allow selection of cohorts most likely to decline during the study period, maximizing the ability to detect a
drug/placebo difference. The proposed project will respond to PA-20-200: NIH Small Research Grant Program
(Parent R03 Clinical Trial Not Allowed). In Aim 1, we will develop new deep survival models to predict MCI-to-
AD dementia conversion using baseline measures, by using data from the AD Neuroimaging Initiative (ADNI)
study. We will use data from the NIH funded Center for Neurodegeneration and Translational Neuroscience
(CNTN) as the test data. The majority of the existing deep survival models were developed for right censored
data, but MCI-to-AD dementia conversion is interval censored. When interval censored data are analyzed by
using the methods developed for right censored data, the survival rates are always over-estimated that leads
to the delay in AD dementia diagnosis. We will develop separate prediction models for early stage MCI and
late stage MCI with biomarkers from cerebrospinal ﬂuid (CSF), positron emission tomography (PET), magnetic
resonance imaging (MRI), and clinical measures. Recently, several new biomarkers have been discovered for
AD that are of interest to this study. These include plasma phosphorylated-tau181 (p-tau181), p-tau217, and
the ratio of amyloid-β 42 and amyloid-β 40, and glial ﬁbrillary acidic protein (GFAP). In progressive disorders
like AD, most clinical events are very strongly correlated with the dynamics of the disease. In Aim 2, we will
develop novel survival models for interval-censored data with time-varying longitudinal biomarker data. Built
on our developed penalized survival model for interval censored data using baseline measures, we propose to
extend that model to leverage longitudinal biomarker data to produce more accurate predictions about future
conversion. Biomarkers along with clinical and demographic features were shown to improve the model
performances for right censored data. We expect that the new survival models will be able to improve model
prediction for interval censored data as compared to state-of-the-art models. This project will develop optimal
deep survival models to predict MCI-to-AD dementia conversion for each MCI subgroup. The results of this
project will provide important understanding of how each feature contributes to prediction of MCI-to-AD
dementia conversion.

Public health relevance
Project Narrative This project will increase our understanding of how each individual's clinical measures and biomarkers would predict the time of progression to AD dementia from MCI. We will develop optimal deep survival models for early stage and late stage MCI patients. This project will greatly speed up the time it would take to identify potential MCI patients who are more likely to develop AD dementia in later years.